Functional genomic characterization of diverse bat innate immune mechanisms

PROJECT SUMMARY
Human health can be inextricably linked to our understanding of bats, as bats are known or predicted
reservoirs for the precursors of many zoonotic viruses. Unfortunately, we still know little about bat immunology,
and we do not know what characteristics allow them to survive with the same viruses that can readily kill other
hosts such as humans. This problem is exacerbated by the fact that bats are an incredibly diverse order of
mammals, so what we learn about the immunological mechanisms of one bat species may not be true for
another. We need new techniques and technologies to efficiently explore the vast unknown universe of
immunological mechanisms that exist across diverse bats. In this application, we propose to develop key tools
needed to functionally characterize the genetic underpinnings of bat immunology. In the first aim, we propose
to pair modern advances in recombinant DNA synthesis and cell engineering to more comprehensively
investigate the function of orthologous genes already proposed to be important in bat immune homeostasis.
We will focus our investigations on STING, a key node in the cytoplasmic nucleic acid sensing pathway. We
will characterize a dozen diverse STING orthologs across Chiroptera to determine whether the same
regulatory mechanisms exist across the order, or if multiple distinct regulatory mechanisms exist. We will
narrow down the genetic determinants underlying these mechanisms by developing and applying “chimeric
mutational scanning”, where we will create libraries of human-bat STING chimeras to identify the key residues
that confer bat-specific regulation to signaling. In the second aim, we will shift our focus to identifying
previously unappreciated immune genes and pathways present in bats. We will perform this with an unbiased
transposon mutagenesis approach, which will be applied to cell lines from diverse bat species. Selection and
sequencing of mutagenized bat cells resistant to the cytopathic effects of Vesicular Stomatitis Virus (VSV)
replication, a proxy for rabies virus, will reveal innate immune genes that allow bats to survive infection. The
mutagenized cells will also be exposed to VSV-EboGP (VSV pseudotyped with the Ebola virus glycoprotein),
mimicking the mechanism used by Ebola virus to enter cells. Thus, with little extra effort, the same library will
be used to identify bat innate immune genes that confer resistance to two zoonotic viruses thought to use bats
as an animal reservoir. This work will both create the technologies needed to explore and understand the
unknown aspects of bat immunity, and generate biological findings directly improving our understanding of bat
innate immune mechanisms. These complementary approaches span a wide field of scope, from the functional
interrogation of the importances of individual amino acids within known innate immune genes, to the whole
genome level to highlight additional genes that should be the subject of focused investigation in the future.

Public health relevance
PROJECT NARRATIVE The current SARS-CoV-2 pandemic has demonstrated that bat zoonoses can have wide ranging and devastating impacts on human health and society, and although we have long acknowledged that bats present a weak point for zoonotic spillover due to their ability to harbor many viruses without pathogenic consequence, progress towards understanding their unique immunology has lagged due to a lack of tools to study their immune system. Here we propose a project that will develop two valuable technologies that will help elucidate bat immunology, with the first investigating the impact of bat sequence diversity on key innate immune molecules, and the second identifying previously unknown bat specific resistance factors that inhibit RNA virus replication. By both developing the biotechnological tools and using them to gain scientific insight, this application will draw a blueprint that other scientists can follow to further understand bat immunity and its relationship with potentially zoonotic viruses, which is critical for reaching the level of knowledge needed to prevent future pandemic zoonoses from bats.